Advancing Transplantation Outcomes in Children

Project Summary/Abstract
Renal transplantation is widely recognized as the treatment of choice for children with end stage renal
disease (ESRD). The life expectancy benefit is significant and a functioning renal transplant enables
children to grow well, develop almost normally and improve their school educational performance levels.
However, current data indicate that virtually all grafts in pediatric recipients will eventually fail due to chronic
allograft dysfunction, and as such, the goal of preserving long-term allograft function is the key area for
future progress. Furthermore, registry data indicate that opportunistic infections are now the most common
cause for hospitalization and death in the pediatric population. Little is known about pathogen-specific
protective immunity in pediatric recipients who are exposed to multiple novel infectious agents throughout
the post-transplant period in the absence of Tmemory. Our approach in this trial is based on the concept
that successful preservation of long-term allograft function requires an immunosuppressive regimen that
targets donor specific alloantibody (DSA) production while preserving pathogen-specific immunity. We also
propose that pediatric recipients require precision tools to monitor, identify and prevent silent subclinical
intragraft inflammation/rejection, which is common at early times in the post transplant period. Based on a
recent pilot study using de novo Belatacept therapy in combination with an mTOR inhibitor (mTORi) in
pediatric recipients, we will test the hypothesis that early introduction of a Belatacept/sirolimus maintenance
immunosuppressive regimen is safe and efficacious in children to augment immunoregulation, prevent DSA
production and enhance long-term allograft function. EBV seropositive primary renal transplant recipients,
aged between 6 and 21 yrs, from eleven experienced pediatric clinical centers will be randomized to receive
induction therapy with anti-thymocyte globulin and either Belatacept therapy in combination with sirolimus or
remain on standard immunosuppression therapy using tacrolimus and mycophenolate mofetil. Primary
endpoint analysis includes de novo DSA development and assessment of allograft function after 36 months
of follow up. Associated studies include surveillance monitoring using a novel automated point-of-care urine
biomarker assay, and in-depth mechanistic studies on the cellular basis for pathogen-specific immunity and
evaluation of functional antibody responses to vaccine. Extensive mechanistic studies will also be
performed to assess the impact of Belatacept/mTORi on cellular and humoral alloimmunity and the further
development of urinary biomarkers to differentiate subclinical rejection from infection. There are significant
unmet clinical needs in pediatric recipients who have unique pathogen-specific and alloimmune responses
following transplantation. Overall, the relevance of this proposal is that it builds upon previous trials to test if
a novel agent (Belatacept) targets allograft dysfunction; in-depth mechanistic monitoring will allow for the
prediction of patient course, and our findings will be applicable to recipients of other solid organ transplants.

Public health relevance
Project Narrative Organ transplantation is a life saving therapy for pediatric patients with end stage renal disease, but all transplants eventually fail due to a process called chronic allograft rejection. In addition, opportunistic infections have emerged as a major cause of morbidity and mortality in pediatric kidney transplant recipients. In this proposal, we have assembled a consortium of experienced transplant centers to perform a clinical trial with potential to advance point-of-care, develop an understanding of pathogen-specific immune responses and promote long-term allograft survival.